Regulation of Vascular Calcification by Adventitial Endothelial Cells

PROJECT SUMMARY/ABSTRACT
Vascular calcification affects ~60% of adults over 60 years of age and is frequently seen in patients with
atherosclerosis. Atherosclerotic calcification is an independent risk factor for cardiovascular morbidity and
mortality. Despite decades of research, no medical therapy has been convincingly established to prevent or
reverse vascular calcification. The intimal (luminal) endothelium forms the innermost layer of the vasculature.
Under disease conditions, the intimal endothelial cells (ECs) are stimulated to transform into osteoprogenitor
cells through endothelial-mesenchymal transitions and contribute to vascular calcification. ECs in the adventitia
contribute to neoangiogenesis in vascular disease. However, little is known about whether adventitial ECs are
associated with vascular calcification. During bone development, a subset of ECs defined by high expression of
the EC marker CD31 and the glycoprotein Endomucin (Emcn) are critical for bone formation. Our preliminary
study using Matrix Gla Protein (Mgp) knockout (Mgp-/-) mice as a model of vascular calcification revealed two
distinct populations of ECs in the calcified aortas, the intimal ECs (i-ECs) defined by CD31+Emcn- and the
adventitial ECs (a-ECs) characterized by CD31+Emcn+. These two EC subtypes with distinct Emcn expression
levels were also detected in human calcified arteries. Bulk RNA sequencing studies showed i-ECs were enriched
in stem cell and osteogenic markers and a-ECs exhibited upregulated Notch expression. Endothelial deletion of
the Notch1 gene reduced vascular calcification and increased the survival of the Mgp-/- mice. In this proposal,
we hypothesize that a-ECs support the biomineralization in the vascular calcification in animal models and
human atherosclerotic lesions, and are closely regulated by Notch signaling. In Aim 1, we will define the
molecular signature of the a-EC (CD31+Emcn+) population in vascular calcification using single cell RNA
sequencing. We will delineate the developmental trajectories of a-ECs in vascular calcification with correlation
to the extent and severity of calcification. In Aim 2, we will determine the contribution of endothelial subtypes (a-
ECs and i-ECs) and Notch signaling in atherosclerotic calcification. We will investigate the effect of endothelial-
specific deletion of the Notch1 receptor on EC subtypes, calcification and transcriptional profiles in
atherosclerotic lesions. The proposed studies will provide novel insight into the fundamental mechanisms of
endothelial cell biology in atherosclerotic calcification and may identify potential gene targets for selective
therapeutic modulation. Together with the mentored career development plan, the completion of the projects will
serve as a foundation to facilitate the candidate to transition into a successful and independent physician scientist
in cardiovascular research.

Public health relevance
PROJECT NARRATIVE Vascular calcification is the pathological deposition of minerals in the walls of the blood vessels, leading to the hardening and increased stiffness of arterial walls, and increased cardiovascular morbidity and mortality. In this proposal, we aim to define the effects of endothelial cells from the adventitia, the outmost layer of the blood vessels, on the development and progression of atherosclerotic calcification, and identify the unique molecular signature of these adventitial endothelial cells. The completion of the proposed studies may pave the way to develop novel therapeutic strategies to selectively target these endothelial cells, thereby attenuating atherosclerotic calcification.